Testing the Efficacy of A Scalable, Telephone-Delivered, Guided Imagery Tobacco Cessation Intervention

PROJECT SUMMARY
We are requesting this administrative supplement to allow us to: 1) recruit diverse participants in Arizona and
West Virginia; 2) hire additional screening staff to handle the increased volume of potential participants; and 3)
provide additional nicotine replacement therapy to participants based on new guidelines and higher-than-
expected tobacco use reported by participants.

Public health relevance
PROJECT NARRATIVE The goal of the proposed project is to conduct a randomized clinical efficacy trial (RCT) of a novel guided imagery tobacco cessation intervention delivered by phone. The results of our feasibility trial conducted in Arizona demonstrated feasibility and potential impact but was not powered to detect efficacy. Therefore, a fully powered RCT is warranted and will be conducted in collaboration with partners in Arizona, New York, and West Virginia.